Project 2: Understanding population disparities in methotrexate neurotoxicity and its impact on short- and long-term adverse outcomes among children and adolescents with acute lymphoblastic leukemia

Project Summary
Improvements in the treatment of childhood acute lymphoblastic leukemia (ALL), including the adoption of risk-
adapted, multi-agent chemotherapy, have resulted in five-year survival rates exceeding 85% in most developed
countries. The antifolate agent methotrexate (MTX) is a critical component of curative pediatric ALL protocols.
Approximately 10% of pediatric ALL patients experience acute neurotoxicity following intrathecal (IT) or high-
dose intravenous (IV) MTX. However, Latino children appear to experience MTX-associated neurotoxicity more
frequently. Further, the clinical management of MTX-related neurotoxicity often involves treatment delays and/or
modifications, which may limit anti-leukemic efficacy and impact survival. A number of factors likely contribute to
disparities in pediatric ALL neurotoxicity and related treatment outcomes, including clinical characteristics,
disease features, and socioeconomic factors. Notably, racial and ethnic disparities in pediatric ALL outcomes,
including relapse and certain late effects of therapy, can be explained in part by underlying variation in genetic
ancestry, suggesting the frequency of variants involved in antileukemia therapy pharmacodynamics and
pharmacokinetics vary across ancestral populations. Our overall goal is to better understand the factors
contributing to disparities in treatment-related toxicities and treatment outcomes among Latino children and
adolescents with ALL and work toward modifying their risks. Our overarching hypothesis is that underlying
germline genetics, tumor biology, and social determinants of health contribute to poorer outcomes in this
vulnerable population. To address our goal, we propose the following three specific aims. Aim 1: Validate and
extend risk prediction models for acute MTX neurotoxicity among a contemporary multiethnic population of
children with ALL. Aim 2: Determine the impact of acute MTX neurotoxicity on ALL relapse, adjusting for currently
known risk factors, using the complete REDIAL Cohort (n>4,300; 50% Latino). Aim 3: Determine the impact of
acute MTX neurotoxicity on long-term neurocognitive deficits, using the Retrospective REDIAL Cohort (n=2,958;
50% Latino). This project will provide insights into the factors responsible for increased neurotoxicity and
subsequent increased risk of relapse and long-term neurocognitive deficits in Latino children with ALL.

Public health relevance
Narrative The antifolate agent methotrexate (MTX) is a critical component of curative pediatric acute lymphoblastic leukemia (ALL) protocols. However, 10-15% of pediatric ALL patients experience acute neurotoxicity following intrathecal or high-dose intravenous MTX, with Latino children experiencing an increased risk of MTX neurotoxicity compared to non-Latino White children. This project will provide insights into the factors responsible for increased neurotoxicity in Latino children with ALL and will determine if the increased toxicity contributes to higher rates of relapse and long-term neurocognitive deficits also experienced by this group.